Pittsburgh Innovation in Collaborative Training of Residents Alliance

ABSTRACT. A critical need exists to enhance the clinician-investigator workforce and cultivate the next
generation of clinician-investigators to pursue heart, lung, blood, and sleep research across the spectrum from
basic/pre-clinical to clinical medicine. While many trainees express an interest in research during residency
training, clinical demands limit opportunities to engage in meaningful, longitudinal investigations and acquire the
fundamental skillsets that build the foundation of a clinician-investigator career. The overarching goal of the
Pittsburgh Innovation in Collaborative Training of Residents Alliance, or PICTOR Alliance program, is to recruit,
retain, and accelerate independence of a pool of resident-investigators to perform basic translational and clinical
translational research using a highly integrative approach that draws upon the experience of a diverse group of
established investigators focused on heart, lung, blood, and sleep research. The PICTOR alliance program will
leverage existing mechanisms to recruit, select, and train the next generation of clinician-investigators within the
Medicine, Pathology, Pediatrics, and Surgery departments at the University of Pittsburgh while developing an
innovative, formalized structured program that integrates the four departments with the specific goal of training
resident-investigators. Up to four outstanding residents per year will be selected to participate in either a basic
translational or clinical translational track that will consist of an initial immersion in concentrated coursework
designed to provide exposure to fundamental areas of life-science or biostatistics, followed by mentored research
with tailored methodology training. As learning is a continuous pursuit through the lifetime of a career, PICTOR
will include self-reflection, peer observation, and team building opportunities for resident-investigators through
the creation of a central hub for peer exchange of ideas, team problem-solving and support, with the ultimate
objective of promoting resilience and capacity for continued growth. A strong foundation of basic translational
and clinical translational research exists at the University of Pittsburgh and the four departments have a rich
history in training clinician-investigators in areas reflective of the NHLBI mission. Cross-disciplinary interactions
will be promoted at the time of recruitment, through the stages of research immersion, and following the
dedicated training period of one to two years. The four departments will likewise collaborate at the organizational
level to provide supervision of the mentored experience to assess research competencies and milestones for
resident-investigators. PICTOR alliance is an immersive structured program that promotes diversity of science
and representation with the ultimate objective of transitioning promising young resident-investigators to individual
career development research awards.

Public health relevance
PROJECT NARRATIVE Many trainees express an interest in research during residency training, but clinical demands limit the opportunity to engage in meaningful, longitudinal investigations and/or to acquire the fundamental skillsets that build the foundation of a clinician-investigator career. The overarching goal of the Pittsburgh Innovation in Collaborative Training of Residents Alliance, or PICTOR Alliance program, is to recruit, retain and accelerate independence of a pool of resident-investigators to perform basic translational and clinical translational research using a highly integrative approach that draws upon the experience of a diverse group of established investigators within four clinical departments (Medicine, Pathology, Pediatrics, and Surgery) focused on heart, lung, blood, and sleep research.